Behavioral Medicine Research in Cardiovascular Disease

Project Summary/Abstract
The purpose of the training grant program is to provide systematic multidisciplinary predoctoral and
postdoctoral research training into the biobehavioral, biological, psychosocial, sociocultural and population
based public health factors involved in the pathogenesis, treatment and prevention of cardiovascular disease
(CVD). Research training is also offered for study of neural and hormonal mechanisms that link biobehavioral
variables to cardiovascular pathophysiology and CVD. The framework for this research is cardiovascular
behavioral medicine, which involves the integration of population-based public health studies, clinical
investigation and basic science. In the present iteration of our program we have successfully incorporated the
research training of Public Health Science pre- and post-doctoral trainees and in the proposed competitive
renewal we intend also to train post-doctoral level physicians in relevant clinical-translational research. One of
the major objectives of the training grant is to mentor trainees into developing a coherent research portfolio. All
of our trainees have a primary preceptor and at least one co-mentor. Of 2 post-doctoral and 5 pre-doctoral
trainees all have presented a poster or oral presentation for at least one national or international scientific
meeting. All trainees are currently active in supervised journal manuscript writing and all have had papers
accepted by refereed journals or had manuscript proposals approved by the MESA, HCHS/SOL and/or similar
publications committees. A major emphasis in the human aspect of this research has been on ethnic/racial
diversity and minority health. A final objective of our training program is the placement of trainees in research
positions, where as evidence of scholarly productivity they develop major funded research programs. During
the past 10 years more than half of our trainees have secured positions in which they are heavily engaged in
research; several have been successful in obtaining extramural research funding. Given the trajectory of our
program, we look forward to even greater productivity in the near future.

Public health relevance
Project Narrative The research conducted by our trainees involves studying the behavioral, biological and social factors that influence cardiovascular disease as well as processes and procedures that may prevent or amelioriate such diseases. From a public health perspective our research is particularly important because it focuses upon relatively poor underserved people, health disparities and understudied groups including Hispanics/Latinos who are not fluent in English.